Noninvasive assessment of coronary endothelial function by multi-slice MRI

Coronary artery disease (CAD) remains a leading and important cause of disability and premature death in the
United States. Conventional clinical imaging characterizes coronary artery anatomy, but because most acute
coronary events result from plaque rupture in regions previously exhibiting less than 50% luminal stenosis,
current state-of-the-art anatomic imaging cannot predict where plaque progression and events will occur. A
new approach is needed and evidence suggests that coronary endothelial function (CEF) imaging can fill this
gap. CEF is considered a “barometer” of vascular health because endothelial release of nitric oxide in
response to certain stressors is a defining characteristic of healthy vascular tissue that results in arterial
dilatation and increased blood flow. Impaired endothelial nitric oxide release, or endothelial dysfunction, is a
marker for sub-clinical disease, an independent predictor of future CAD progression and cardiac events, and
responds favorably to beneficial medical interventions. Despite the well-established diagnostic and prognostic
importance of CEF, it is rarely measured in clinical practice because it was mostly measured with invasive
cardiac catheterization. We recently developed a noninvasive magnetic resonance imaging (MRI) means to
quantify local CEF that combines 2-dimensional (2D) cine MRI with isometric handgrip exercise (IHE). The
main limitation is that the 2D approach only allows CEF measurements at just two to four locations and
therefore cannot characterize CEF in multiple arteries or regional heterogeneity present throughout a diseased
coronary artery. The aims of our proposal are 1) to develop a new multi-slice MRI method that to assess CEF
area changes along proximal to mid segments in all major coronary arteries; 2) to optimize and validate the
proposed method’s ability to measure cross sectional areas by assessing both accuracy and precision; and 3)
to validate the CEF measures from the proposed method against the noninvasive gold-standard including
reproducibility testing in both healthy subjects and stable CAD patients. This work will provide a robust,
noninvasive means to better and more comprehensively assess CEF, an independent predictor of future
atherosclerotic progression and events, and barometer of response to therapy. Knowledge of accuracy,
precision, and reproducibility values will enable us to design future studies investigating novel interventions
and monitoring disease progression.

Public health relevance
Conventional imaging exams of heart vessels try to identify the presence of blockages in blood vessels that can obstruct blood flow, but that information cannot predict where new blockages leading to heart attacks will occur in the future. Instead, measurements of a blood vessel’s health, reflected in its changes in size and blood flow in response to stress, predict adverse clinical events but are rarely used clinically because they require invasive imaging techniques. This work will develop novel noninvasive imaging techniques with magnetic resonance to assess blood vessel health by measuring changes in vessel size throughout all major coronary artery vessels in response to a standard and well-established stressor.